Selective Transformations of Common Feedstocks to Functionalized Amines and Heterocycles

Principal Investigator/Program Director (Last, First, Middle): Rovis, Tomislav
Selective Transformations of Common Feedstocks to Functionalized Amines and Heterocycles
Abstract
Nitrogen is the fourth most common element found in FDA-approved drugs, occurring in 88% of the
>1000 unique small molecules. The installation of nitrogen into bioactive molecules and pharmaceuticals
impacts interactions with biological targets, pharmacokinetics, and pharmacodynamics, as well as myriad
physical properties. Given the increased importance of saturation in drug-like molecules, carbon–nitrogen
bonds are increasingly stereogenic and thus, methods to incorporate nitrogen should likewise address doing
so in stereocontrolled fashion. At the same time, nitrogenated scaffolds are increasingly available from vendors
as feedstock chemicals. Amines (in addition to carboxylic acids) are increasingly present in compound libraries
given the prominence of amides and the ease of synthesis of this key bond.
Herein we propose a multi-pronged approach to synthesize complex structures containing nitrogen
substitution from simple precursors, as well as design novel transformations that employ nitrogenous groups
as functional handles for further chemical diversification. We seek to address unmet needs in heterocycle
synthesis using feedstock chemicals like alkenes and simple alkanes with direct installation of C–C and C–N
bonds, obviating post-introduction manipulations. We further aim to transform common amines with either C–H
functionalization chemistry or with C–N activation methods for cross-coupling. Taken together, these methods
will enable installation and derivatization of nitrogen-containing molecules in a selective fashion while
streamlining synthesis to access structures that are highly challenging or impossible to prepare otherwise.
PHS 398/2590 (Rev. 09/04) Page Continuation Format Page

Public health relevance
Project Narrative One of the most significant barriers to health-related research involving small molecules is the rapid assembly of therapeutic agents. This proposal seeks to develop new methods to synthesize complex frameworks using easily accessible precursors with high efficiency.